New tools for quantitative non-invasive recording of biochemical signals

ABSTRACT
Chimeric antigen receptor (CAR) T-cells are a revolutionary cancer treatment, with the particular benefit of
generating memory T-cells that can last for years and suppress cancer relapse. CAR-expressing CD8+ T-cells
have been shown to cure leukemia and other cancers in clinical trials with great success. However, many
challenges remain before CAR-based immunotherapy can become widely adopted, particularly for solid tumors.
A major problem is that CAR T-cells become “exhausted” or “dysfunctional” and display decreased therapeutic
effectiveness when subjected to prolonged antigen stimulation in the tumor microenvironment. Elevated cytosolic
calcium is associated with T-cell activation, and as such, calcium signaling activity can be used as a quantitative
measure of T-cell function or dysfunction. The history of calcium signaling over short and long periods of time
encodes information about the current functional capacity of the T-cell and the number of tumor cells encountered
in the past, and can be used both to evaluate populations or individual clones and to select for clones resistant
to exhaustion. However, imaging calcium signaling activity in vivo using traditional genetically encoded
fluorescent indicators presents unique challenges with T-cells and other highly mobile cell types, especially
when medium- to long-term activity tracking is required. There is currently no facile method to image calcium
signals at the single-cell level over long time periods or to track calcium activity history in such a highly mobile
cell population, either in vitro or in vivo. In this project, we will use several distinct varieties of photoactive
fluorescent proteins coupled with a family of high-contrast bioluminescent calcium sensors to generate Optical
Recorders for Calcium (ORCas) capable of reporting short-, medium-, and long-term calcium signaling histories
in CAR T-cells upon repeated exposure to target tumor cells. We will additionally engineer the small molecule
substrates used to time-gate history recording for improved bioavailability and cell specificity, and to diversify the
wavelengths of light emitted by the bioluminescent sensor domains of these probes. The engineered ORCas will
ultimately be used to (1) track the exhaustion status of CAR T-cells over long periods of repeated exposure to
target tumor cells, (2) enrich exhaustion-resistant populations of CAR T-cells from CRISPR knockout libraries,
and (3) quantitatively benchmark the exhaustion resistance of CAR T-cell clones. These probes will additionally
be validated in CAR T-cells in vivo in a subcutaneous mouse tumor model. Ultimately, we anticipate that ORCas
will be the first of a broad new class of genetically-encoded probes capable of recording specific biochemical
signal history non-invasively in many disease models and therapeutic interventions.

Public health relevance
PROJECT NARRATIVE In this project, a new class of biological reporters will be developed and deployed to identify key bottlenecks in the translation of CAR chimeric antigen receptor (CAR) T-cell therapy, an emerging therapeutic approach to cancer treatment. This work will reveal new avenues to improve the overall general performance and durability of CAR T cells, by enabling researchers to easily view the history of calcium signaling in these cells. The imaging probes leverage state-of-the-art bioluminescent and fluorescent proteins, which naturally emit and transform light, to build probes that non-invasively record biochemical activities in living cells.